Understanding the Regulation of Translational DEAD-box Helicases during Stress

ABSTRACT
Adaptation to environmental stressors is essential for cellular survival, and regulation of
translation plays a central role in this process by modulating protein levels and maintaining
proteostasis. One key step in translation regulation is initiation, where messenger RNA (mRNA)
is prepared for translation by recruiting ribosomal subunits. In eukaryotes DEAD-box helicases
serve as translation initiation factors that activate mRNAs for translation and facilitate ribosomal
scanning of the 5′ untranslated regions (UTRs) of transcripts. Despite their importance in
maintaining proteostasis, the dynamic regulation of these helicases in response to stress remains
poorly understood. We recently discovered a potential mechanism to regulate DEAD-box helicase
activity during stress conditions when the mRNA cap-binding protein eIF4E is depleted. Disrupting
this putative regulation reduces growth during eIF4E depletion, but paradoxically increase protein
synthesis. Thus, I hypothesize that the loss of this DEAD-box helicase regulation disrupts
translation and proteostasis during stress, leading to cytotoxic protein aggregation and reduced
fitness. In Aim 1, I will test the proposed regulation of DEAD-box helicase activity by measuring
changes in helicase function in vitro. In Aim 2, I will examine the translational and proteostatic
effects of ablating DEAD-box helicase regulation during translational stress caused by eIF4E
depletion. In Aim 3, I will identify additional environmental stressors where DEAD-box helicase
regulation is critical, expanding our understanding of how translational control adapts to cellular
perturbations. This project will provide new insights into the mechanisms of translational
regulation during stress and highlight how cells dynamically adjust protein synthesis to maintain
proteostasis in changing environments.

Public health relevance
NARRATIVE Dynamic regulation of gene regulation in different environmental contexts is implicated across many diseases. The proposed research aims to understand the molecular mechanisms and physiological function of regulating DEAD-box helicases in the budding yeast S. cerevisiae during translational stress.